Illuminating the gene regulatory strategies underlying yeast meiosis and beyond

Abstract. Meiosis is the conserved differentiation program that creates gametes. It fails frequently, with
devastating consequences for human fertility and health. As a cell progress through meiotic differentiation, it
undergoes irreversible changes in cellular structure and function that are largely driven by gene expression
changes. Because the molecular basis for most meiotic transitions remains mysterious, my lab aims to
illuminate the gene regulatory circuitry that programs meiotic differentiation. We use budding yeast to
study this process because this organism uniquely offers access to the large number of highly synchronous cells
that is key to genomic approaches that we routinely employ. Our studies have uncovered major surprises in
the genes that meiotic cells express and how they regulate these genes, revealing big gaps in our fundamental
understanding of how gene expression works in meiosis, and beyond. These findings have led us to believe
that meiosis is a valuable model for identifying and interrogating such broad open questions in gene regulation.
Among the surprises we found is the common use of an unconventional mode of gene regulation,
involving regulated toggling between a translatable mRNA isoform and one that is 5' extended and poorly
translated. A major focus of our future research is to better understand why some of these 5' extended “long
undecoded transcript isoforms” (LUTIs) are subject to nonsense mediated decay (NMD), while other are
protected from degradation. We will use approaches including machine learning analyses of targeted and
protected classes of LUTIs, integrating data including their in vivo structures, to identify NMD transcript cues.
This project will not only help us understand the true prevalence of LUTIs in yeast, it aims to leverage this large
newly identified class of natural NMD targets to elucidate central principles in NMD targeting in all cellular
contexts. We will also use the knowledge gained from our studies of LUTI-based regulation in yeast to determine
whether it is a similarly widespread core mode of gene expression regulation in mammalian cells.
We also discovered that meiotic cells translate many coding regions were not previously identified. These
include hundreds of proteins that are translated starting with non-AUG codons, and thousands that are shorter
than the 100 codon cutoff that was used to annotate genomes. We are studying the specific cellular roles of
short proteins by performing pooled screens and focusing on directed study of cases in which the short proteins
include domains of characterized proteins. Our goal is to reveal the types of functions mediated by this large and
poorly studied class of cellular factors that are now known to be commonly in eukaryotes. Finally, MIRA funding
enabled development of an entirely new project in my lab, one that studies the way that protein complex
members find each other within the complex environment of a cell. This project has the potential to reveal
fundamental principles in cellular regulation, enabled by our background in meiosis, the simplicity and power
of the yeast system, and our expertise in global gene expression dataset generation and analysis.

Public health relevance
Project Narrative Meiosis is an evolutionarily conserved process by which a precursor cell is remodeled to produce gametes, which enable sexual reproduction. The proper execution of these cellular remodeling events is critical for production of viable gametes and is controlled by changes in which genes are turned on (expressed) at different stages of the process. My lab has recently defined the natural gene expression changes that occur during meiosis, discovering aspects to this regulation that defy expectations based on traditional models, and prompting important questions about how gene expression is regulated—in meiosis and beyond—that we will now investigate.